THE EFFECT OF RTMS-INDUCED CORTICAL INHIBITION ON VISUOSPATIAL MOTOR SSKILL ACQU

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of this study will allow for a greater understanding of the underlying neural mechanisms involved in motor skill learning and facilitate development of effective neurologic rehabilitation strategies.